Mitochondrial iron export therapy for doxorubicin-induced cardiotoxicity

PROJECT SUMMARY/ABSTRACT
Doxorubicin is routinely prescribed in treatment of various cancers because of its extremely high efficacy.
However, its use is severely limited because of its potential to cause irreversible cardiotoxicity. Since cessation
of therapy is not viable in cancer patients, there is a need to explore the molecular mechanisms underlying
cardiotoxicity to accurately identify risk factors as well as therapeutic targets for effective adjuncts. The primary
mechanism by which doxorubicin exerts its cardiotoxic effects is due to preferential accumulation of excess iron
in cardiac mitochondria, which generates cytotoxic free radicals, and disruption of cellular and subcellular iron
utilization. Thus, chelating excess mitochondrial iron can prevent doxorubicin-induced cardiac dysfunction.
Indeed, the only drug approved to treat doxorubicin cardiomyopathy, dexrazoxane, has demonstrated
mitochondrial chelation potential. However, dexrazoxane alters topoisomerases, the enzymes responsible for
DNA replication and doxorubicin’s pharmacological target, which thereby impairs doxorubicin’s anticancer
activity. In addition, dexrazoxane has potential to induce fatal myelosuppression and acute leukemias, which
consequently limit its clinical utility. Cancer survivors who subsequently develop cardiomyopathies have the
worst survivals among all cardiomyopathies, and timely intervention results in a superior clinical outcome in those
survivors treated with cardiotoxic chemotherapy. Thus, there is a major unmet need for mitochondria-specific
iron chelators that do not impede doxorubicin’s antitumor activity. Earlier we have demonstrated that hinokitiol,
a small molecule with high iron binding affinity and cell permeability, corrects abnormal iron buildup across the
membrane caused by genetic deficiency in mitochondrial iron transporters. These findings prompted us to
question if hinokitiol could rescue doxorubicin-induced mitochondrial accumulation of iron. Our pilot study has
indicated a feasibility that hinokitiol corrects mitochondrial iron overload and improves survival in cardiac cells
treated with doxorubicin with no influence on tumor-killing effect of doxorubicin. Thus, we hypothesize that
hinokitiol mobilizes excess iron from the cardiac mitochondria and prevents oxidative damage, thereby reversing
doxorubicin-induced cardiomyopathy, while preserving doxorubicin’s anticancer activity. The specific aims are
to determine: i) mitochondrial iron export after hinokitiol administration, ii) the cardioprotective effect of hinokitiol
on doxorubicin-induced cardiotoxicity, and iii) the effect of hinokitiol on the antineoplastic efficacy of doxorubicin
using tumor-bearing mice. Our studies will provide a new therapeutic strategy to reverse abnormal accumulation
of mitochondrial iron and correct doxorubicin-induced cardiotoxicity without compromising its antineoplastic
effects. If successful, this drug can be safely co-administered with doxorubicin as a rescue factor to improve the
therapeutic index of doxorubicin along with better clinical outcome.
.

Public health relevance
PROJECT NARRATIVE Doxorubicin is one of the most efficacious anticancer agents in the treatment of several solid tumors as well as hematological malignancies, but its utility is severely limited by its induction of cardiotoxicity and cardiomyopathy. This occurs due to the ability of doxorubicin to promote the accumulation of redox-active iron into the cardiac mitochondria, but current iron chelators do not offer clinical benefits since they are mitochondrial-inaccessible or impede doxorubicin’s antitumor efficacy. We report a new class of a small molecule that provides selective and efficient iron removal from the mitochondria without affecting doxorubicin’s antitumor activity, which has the potential to revolutionize approaches in many anthracycline- based cancer therapies.